EDITORIAL AND ELECTRONIC COMMUNICATIONS SUPPORT

The objective of this contract is to provide the necessary support for NIMH's print and electronic communications program. The contract provides editorial support services (including writing and/or researching manuscripts, rewriting, editing, proofreading, indexing, desktop publishing, Spanish translation and production and testing of low-literacy materials) and electronic communications support (including preparation of materials for display on the WWW and advice on web site design). Production of the Schizophrenia Bulletin, a highly respected, peer- reviewed journal published by the Institute largely is carried out by means of this contract.